FUNCTIONAL ABDOMINAL PAIN IN CHILDREN--RELAXATION/GUIDED IMAGERY &CHAMOMILE TEA

DESCRIPTION: Functional bowel disorders are defined as variable combinations of gastrointestinal symptoms that are not readily explained by structural or biochemical abnormalities. In children, these typically encompass irritable bowel syndrome and recurrent abdominal pain of childhood, two closely related disorders that reflect similar pathophysiologic processes. Both of these functional disorders are pervasive in children and possibly precede symptoms that persist into adulthood. These also account for considerable medical expense and morbidity resulting in school absenteeism. Existing therapies are limited, and the lack of success frequently frustrates parents, families, and physicians. The purpose of this pilot project is to explore the use of alternative medicine modalities to treat functional abdominal pain relying on those that address currently accepted pathophysiologic models of functional bowel disorders. Available evidence indicates 3 major mechanisms for these syndromes: altered intestinal motility, altered intestinal sensory thresholds, and psychosocial factors. Recurrent abdominal pain occurs in 10 to 30 percent of children and adolescents, and evidence suggests that many children with recurrent abdominal pain ultimately develop symptoms compatible with irritable bowel syndrome in adulthood. As many as 68% of school children suffering from recurrent abdominal pain have symptoms compatible with the diagnostic criteria for irritable bowel syndrome in adults. Colonic motility studies suggest exaggerated colonic motor function in patients with abdominal pain compared to controls, increased perception of abdominal pain following balloon distention of the rectum, and anxiety and depression compared to healthy children in the community. The approach to therapy including reassurance, fiber, and antispasmodics has not been effective in the long- term management of a recurrent abdominal pain in childhood. Accordingly, this pilot project will attempt to evaluate objectively two alternative modalities that address some of the mechanisms and could offer therapeutic options. In specific aim 1, a randomized controlled trial will be instituted to confirm the effectiveness of relaxation/guided imagery as a modality for treating functional bowel disorders in children and determine if guided imagery improves outcome beyond that achievable using relaxation training alone. In the second trial, the use of chamomile tea as an adjunct to traditional models of treating functional bowel disorders in children will be assessed and compared to controls who do not receive chamomile tea. The primary outcome will be a reduction in pain measured by a Likert-scale pain inventory using faces as markers. The advantages of this inventory are that faces have been found to be universal across ethnicities and age groups. Secondary outcomes will include bowel habits and stool consistency, measures of functional disability using the Functional Disability Index, and psychiatric profiles using the Child Depression Inventory, Revised Children's Manifest Anxiety Scale, and Children's Global Assessment Scale. In addition, compliance measures will be assessed by phone contact by nurse clinicians. Data management will be undertaken to quantify the analyses already described.